REVAMP-PH: REpurposing Valsartan May Protect against Pulmonary Hypertension

Project Summary
Although there has been substantial progress in the development of medications to lower pulmonary
vascular resistance in pulmonary arterial hypertension (PAH), there are no therapies that are known to
benefit the right heart in the absence of changes in right ventricular afterload in patients with PAH. Right
heart failure is the key driver for morbidity and mortality in patients with PAH, but also complicates a
range of other common diseases such as emphysema, interstitial lung disease, and left heart failure.
We are pursuing a novel approach that targets angiotensin receptors in patients with PAH and right
heart failure. Previous animal studies suggest angiotensin signaling may contribute to myocardial
fibrosis and could also be important in the pathogenesis of PAH and pulmonary vascular remodeling.
Angiotensin receptor blockers are well established in left heart failure where their benefit is not merely
a result of improvement in left heart afterload. Our work has shown a substantially lower all-cause
mortality in veterans with pulmonary hypertension who use angiotensin converting enzyme inhibitors or
angiotensin receptor blockers. These mechanistic and observational results raise the strong possibility
that angiotensin receptor blockade might be an effective treatment for right heart failure.
Angiotensin receptor blockade is an appealing therapeutic target that is well aligned with current NIH
priorities of repurposing existing, inexpensive, and well-tolerated medications for novel use in other
disease states. Medications for PAH are particularly expensive. If adjunctive therapy with an angiotensin
receptor blockers are efficacious, this would benefit PAH patients and society at-large.
We propose a Phase 2, single-center, randomized placebo-controlled trial of valsartan (an angiotensin
receptor blocker) in adults with PAH. The study will evaluate the safety and clinical efficacy of a 24-
week course of valsartan. The primary endpoint is change in six-minute walk distance at 24 weeks.
Secondary endpoints include differences in right ventricular function, biochemical markers of right heart
failure (NT-proBNP), New York Heart Association Functional Class, health related quality of life (as
assessed by the disease specific emPHasis-10 instrument), and the frequency with which routine
therapies for patients with PAH are escalated during the trial.

Public health relevance
Project narrative We propose a randomized controlled trial of valsartan in patients with pulmonary arterial hypertension and right heart failure. There are no current medications that change the natural history of right heart failure. There is ample evidence to suggest angiotensin receptor blockers may impact right heart failure, and - if confirmed by randomized evaluation - this would address a clear unmet need in heart failure management.